Intensive Speech Motor Chaining Treatment and Artificial Intelligence Integration for Residual Speech Sound Disorders

Project Summary/Abstract
Speech sound disorders impacting /ɹ, s, z/ may become chronic due to either ineffective or limited treat-
ment. The long-term goal is to leverage theoretical and technological advancements to accelerate the develop-
ment of accessible and effective treatments that mitigate reduced quality of life due to chronic residual speech
sound disorders (RSSD). To this end, the validated motor-based RSSD treatment Speech Motor Chaining guides
speech-language pathologists (SLPs) through high-fidelity, high-trial, rapidly adapting treatment by dosing and
manipulating several principles of motor learning in real time. SLP-led Speech Motor Chaining has been effective
for individuals whose errors persist after traditional treatment. However, at least two challenges remain: first,
optimal treatment intensity is unknown. Second, SLPs need validated avenues for evidence-based practice when
caseload size precludes optimal intensity. Therefore, the overall objective of this proposal is to optimize a suite
of theoretically motivated, high-fidelity, motor-based treatments delivered at the appropriate intensity, despite
practical barriers, for the sounds comprising 90% of RSSD: /ɹ, s, z/. The central working hypotheses, supported
by our preliminary work, are that Speech Motor Chaining is (a) more efficacious when delivered intensively (i.e.,
closely spaced for a fixed number of sessions), and (b) also beneficial when practice is led by an artificial intelli-
gence (AI) SLP. The theoretical rationale is that increasing intensity early in treatment will mitigate erred prac-
tice between sessions, improving outcomes relative to more customary practice distributions, and that reliable
AI-mediated practice is effective in the context of validated treatments. There are three aims: Aim 1: Deter-
mine how intensive/distributed treatment affects speech sound learning in RSSD. A randomized
controlled trial (n=84) will test the hypothesis that intensive SLP-led Speech Motor Chaining (i.e., bootcamp)
leads to greater gains in speech sound accuracy compared to an equivalent number of customarily distributed
sessions. Aim 2: Determine improvement in /ɹ/ production when Speech Motor Chaining practice
trials are led by an Artificial Intelligence clinician. A multiple baseline single subject design will test the
hypothesis that Chaining-AI, in which an AI SLP provides clinical feedback, facilitates clinically meaningful
change in /ɹ/ production. Aim 3: Demonstrate breadth of clinical AI capability by optimizing mis-
pronunciation classification algorithms for /s/ and /z/. Mispronunciation detection algorithms will be
trained to recognize clinical speech errors affecting /s/ and /z/, replicating expert listener judgement with clini-
cally-acceptable accuracy. This significant research addresses a critical need for theoretical/empirical guidance
for treatment intensity, offering sorely needed recommendations in a system where ~6 million American adults
have unresolved RSSD. This innovative research accelerates a paradigm shift in which combined SLP/AI service
delivery could overcome barriers to effective, accessible, and sufficiently intensive treatment, for 90% of RSSD.

Public health relevance
Project Narrative The proposed research addresses the critical public health need for sufficiently intense speech treatments, without which ~6 million Americans adults live with unresolved speech sound disorders. The project’s investigation of intensive motor-based treatment bootcamps and artificial intelligence-driven treatment potentiates an evidence-based paradigm shift in which combined speech-language pathologist/artificial intelligence service delivery overcomes existing access barriers to sufficiently intense treatment. The project is relevant to the NIDCD’s and NIH’s missions of conducting behavioral research to reduce disability, as those with unresolved speech sound disorders may experience reduced educational, social, emotional, and occupational outcomes throughout the lifespan.